Exploring early protective immune responses to Chlamydia

PROJECT SUMMARY/ABSTRACT
Chlamydia trachomatis is the obligate intracellular bacterium that causes the most prevalent STI worldwide. It
is estimated that over 1.6 million of new cases of Chlamydia occurred in 2021 in the United States. Although
most Chlamydia infections are asymptomatic, “silent” infections can lead to severe sequelae such as pelvic
inflammatory disease, ectopic pregnancy and infertility. Current consensus is that prophylactic measures,
such as a vaccine, are needed to flatten the ever-rising infection curve of Chlamydia. To date, there is no
licensed human Chlamydia vaccine available, and only one subunit vaccine candidate completed a phase I
clinical trial for safety. Understanding how protective immunity is developed in the female reproductive tract
(FRT) against Chlamydia is essential for developing a vaccine. Prior research has established the essential
role of CD4 T cells in protective adaptive immunity against Chlamydia. In contrast, the early innate defense
mechanisms in the FRT are much less well understood in vivo. Our recent studies suggested that innate
IFNg production during early Chlamydia infection is essential for preventing systemic bacterial dissemination.
Moreover, increasing evidence suggest that innate immune cells can acquire immune memory characteristics
through proper “training”. In this application, we propose to (i) explore the landscape of early immune
responses to Chlamydia in the FRT and characterize the heterogenous Thy1+ cell population essential for
protection; and (ii) characterize the myeloid cell infiltrates and determine whether trained immunity induced by
BCG contribute to protective immunity and/or immunopathology during Chlamydia infection. We anticipate that
identifying cellular populations and their effector functions responsible for protective immunity vs pathologic
outcomes in the FRT will provide rational support for developing vaccines for STIs.

Public health relevance
NARRATIVE Chlamydia trachomatis sexually transmitted infection poses critical threats to women’s reproductive health. Our proposed study aims to characterize the early immune responses to Chlamydia infection in the female reproductive tract, and identify major cellular components and their effector functions essential for protective immunity and development of immunopathology. These studies are important for fundamental understanding of host innate immunity to Chlamydia, and will aid the design of a protective Chlamydia vaccine.